Modifying spatial maps to improve localization

PROJECT ABSTRACT Improving speech understanding in the presence of background noise by individuals ﬁtted with cochlear implants is an enormous challenge. Although audibility can sometimes be a limiting factor for beneﬁt, more frequently it is because the cues that are often responsible for sound source segregation by individuals with normal hearing, are limited or unavailable. This proposal will alter binaural cues, in the form of magniﬁed ILDs, and deliver them over time to bilateral cochlear implant users. The eﬀects of prolonged exposure will be examined, including the potential for binaural plasticity, as expressed by changes in behavioral and electrophysiological measures of binaural processing.

Public health relevance
PROJECT NARRATIVE This project will explore the potential for binaural plasticity in response to prolonged exposure to altered spatial maps that will deliver larger-than-normal binaural cues to bilateral cochlear implant users. The implications for speech intelligibility and localization will be examined using both behavioral and physiological measures.